Anti-ceramide immunotherapy for diabetic retinopathy

Evidence from large-scale clinical trials demonstrate strong association between lipid abnormalities and
progression of diabetic retinopathy (DR), however the mechanism of dyslipidemia induced damage and the
action of lipid targeting drugs in the retina are incompletely understood. Acid sphingomyelinase (ASM) is
upregulated in diabetic retina and pharmacologic, siRNA, or microRNA inhibition of ASM prevented TNF-α and
IL-1β-induced pro-inflammatory changes, barrier breakdown, cell death in retinal endothelial cells (RECs) and
the development of DR. ASM activation results in hydrolysis of sphingomyelin in the outer leaflet of the plasma
membrane to preferentially generate C16-ceramide and ceramide rich platform (CRP) formation. We identified
C16:0/C26:0 ceramide imbalance with pathologic C16-ceramides increasing and retina-specific protective very-
long chain C26-ceramides decreasing in the vitreous of patients with proliferative DR, similar to the C16:0/C24:0-
ceramide ratio identified as a robust predictor of poor outcome from cardiovascular disease.
DR is strongly associated with systemic inflammation; however, mechanisms responsible for circulating cells
impacting the retina remain incompletely understood. Specifically, how diabetes impacts hematopoiesis and
contribution of bone marrow cells to DR remains understudied. Generation of increased numbers of
proinflammatory monocytes and neutrophils is known as myeloid skewing, which we have identified in both T1D
and T2D. While another key hematopoietic population, termed myeloid angiogenic cells (MACs), is severely
diminished in number and function in diabetic patients, including in individuals with DR, and contributes to
inadequate vascular repair. Previously, we demonstrated ASM activation and increase in ceramide in both RECs
and MACs in DR models. Critical to the function of MACs is their ability to egress from bone marrow (BM), enter
the circulation and migrate to areas of injury. MAC mobilization and entry into tissues such as the retina critically
depends on plasma membrane morphology and protein dynamics, which are mediated by membrane fluidity.
Diabetes-induced changes in membrane lipid composition led to MACs remaining “trapped” within BM and
incapable of mobilization into the circulation to mediate vascular repair . ASM inhibition corrected MAC release
and normalized their function in rodent diabetes animal models and corrected retinal pathology. Importantly,
human diabetic MACs, CD34+ cells, exhibit altered membrane fluidity and dynamics. To inhibit ASM-induced
pathology, our program generated anti-ceramide antibody (Ab) to bind CRPs, preventing and mitigating ongoing
apoptosis.
Based on published and preliminary data, we hypothesize that predicting severity of DR in diabetic patients
can be achieved by quantification of CRP formation in peripheral blood cells and that systemic administration of
anti-ceramide Ab will restore physiological hematopoiesis eliminating myeloidosis and preserving MAC
production/ function to prevent/reverse DR.

Public health relevance
Despite recent advances using pharmacotherapy that greatly expanded treatment options for diabetic retinopathy, the cure for this blinding complication is not yet achieved. We identified activation of ASM, the enzyme converting sphingomyelin into ceramide, as a key element affecting both diabetes-induced vascular damage and bone marrow derived circulating angiogenic cell mediated repair of retinal vasculature. This proposal will test therapeutic potential of functional inhibition of ceramide signaling using anti-ceramide immunotherapy.